NALOXONE AND NEONATAL ADAPTATION IN THE HUMAN

CDMAS ONLY: To study the effect of blockade of endorphin by naloxone on the blood levels of stress hormones (catecholamines) during labor and delivery in newborn infants.